Driving Pressure as a Target for Lung-Protective Ventilation

PROJECT SUMMARY/ABSTRACT
Sarina Sahetya, MD MHS is a pulmonary and critical care physician-scientist at Johns Hopkins University, with
a Master’s degree in Clinical Investigation. This K23 proposal will provide her valuable training towards her
long-term career goal of being an independent, NIH-funded, patient-oriented investigator conducting
randomized trials to improve clinical outcomes for patients with acute respiratory failure. Acute respiratory
distress syndrome (ARDS) is a common and frequently fatal type of acute respiratory failure with an overall
mortality ~40%. Mechanical ventilation is a cornerstone of ARDS management. Despite its life-saving effect,
mechanical ventilation also can cause ventilator-induced lung injury (VILI), which can increase morbidity and
mortality. Recently, the COVID-19 pandemic has highlighted the importance of optimal lung-protective
ventilation strategies to improve patient outcomes. Recent observational studies suggest that targeting low
Driving Pressure, as part of a mechanical ventilation approach for ARDS, could improve mortality. This K23
grant builds on Dr. Sahetya’s prior experience with developing physiologically-guided mechanical ventilation
approaches for reducing Driving Pressure. In this K23, she will prospectively evaluate a Driving Pressure-
guided approach to lung-protective ventilation. The research will be completed within the highly supportive
training environment at Johns Hopkins, with the guidance of a team of superb mentors with relevant expertise.
The overall objectives of this K23 Award are to: (1) complete rigorous multi-phase pilot work evaluating a lung-
protective ventilation strategy minimizing Driving Pressure for ARDS patients, and (2) develop essential skills
for the candidate to be a successful independent patient-oriented investigator. The career development plan
combines didactics, with outstanding mentorship in key areas of advanced statistical analysis, rigorous
protocol and trial design optimization via qualitative methods, and conduct of a pilot randomized trial, to ensure
a successful transition to independence. Using a large database of ARDS patients enrolled in a recent NHLBI-
funded trial, Dr. Sahetya will evaluate the relationship between changes in Driving Pressure, arising from
changes in positive end-expiratory pressure, and mortality as well as explore patient characteristics that modify
this relationship (Aim 1). She will use qualitative methods to gain in-depth understanding of clinicians’
perspectives on optimizing the design of ventilation RCTs in order to refine a proposed Driving Pressure-
guided pilot trial (Aim 2). Finally, she will conduct a pilot randomized controlled trial evaluating the feasibility of
a Driving Pressure-guided ventilation strategy compared to the ARDS Network lung-protective ventilation
protocol (Aim 3). This rigorous training and mentored research experience will foster continued productivity,
provide preliminary data for a future NIH R-level grant, and establish a strong foundation for a career
conducting clinical trials of new interventions to improve patient outcomes in acute respiratory failure.

Public health relevance
PROJECT NARRATIVE Acute Respiratory Distress Syndrome (ARDS) is a common, often fatal lung condition for which there are few effective treatments. Use of a mechanical ventilator is critical for survival; however, the ventilator may also cause lung damage and increase risk of death in patients with ARDS. This research evaluates a new approach to mechanical ventilation using the Driving Pressure as a target for lung-protective ventilation, with the ultimate goal of minimizing lung damage and improving survival for ARDS patients.